Deciphering the output of fetal hematopoietic stem and progenitor cells at homeostasis and in response to inflammation

ABSTRACT
Hematopoietic stem and progenitor cells (HSPCs), which include hematopoietic stem cells (HSCs) and
multipotent progenitors (MPPs), give rise to all blood and immune cells across the lifespan. HSCs first emerge
during gestation and ultimately becoming the adult hematopoietic compartment. Human studies have associated
events during pregnancy such as maternal infection, diet, or exposure to microbes with increased risk of immune
dysfunction in offspring; however, the mechanisms behind this are unknown. Since hematopoietic progenitors
arise during gestation and seed the adult hematopoietic compartment, we hypothesize that prenatal inflammation
reprograms the cellular output of distinct fetal HSPCs, thus influencing postnatal immune function. Recent data
has suggested that fetal HSCs and fetal MPPs emerge independently from the intra-embryonic aorta during
development. This suggests that fetal MPPs and fetal HSCs of distinct origin have specific functions and relative
contributions to postnatal blood production at homeostasis and during inflammatory insults, but this has not been
directly investigated. Our working hypothesis is that fetal MPPs drive the response to prenatal inflammation in
order to preserve the HSC pool, shaping the postnatal hematopoietic compartment. We will test our hypothesis
by integrating genetic fate mapping experiments, transplantation assays, transcriptomics, and early life infection
models. Our preliminary data suggests independent emergence of fetal MPPs and fetal HSCs from the
developing aorta and has revealed the first evidence of functional differences between fetal MPPs and HSCs.
We have found that fetal MPPs are the first responders to Type II-IFN mediated prenatal inflammation and
expand the pool of downstream myeloid cells, which remain expanded in the postnatal period. Our findings also
support the idea that timing of emergence influences the functional output of fetal progenitors at steady state
and in response to inflammation. The objective of this proposed work is to comprehensively examine the specific
effects inflammation has on fetal HSCs and MPPs and will define the mechanisms by which prenatal
inflammation shapes the adult hematopoietic system. We will determine how inflammation experienced in utero
influences offspring immunity and response to postnatal immune challenges at the level of fetal HSPCs. We
anticipate that the insights gained from this proposed work will help inform underlying causes of disease that
may start during development.

Public health relevance
PROJECT NARRATIVE Fetal hematopoietic stem cells (HSCs) and multipotent progenitors (MPPs) are critical for the development of the adult blood and immune systems, but how these progenitors respond to prenatal inflammation or early life infections, and how this impacts offspring immunity remain poorly understood. We hypothesize that distinct fetal MPP populations mediate the response to prenatal inflammation and generate immune cells that may protect the offspring from early life-infections, while preserving the fetal HSC pool. The objective of this grant is to define the function and cellular output of specific fetal HSCs and fetal MPPs over time, both at steady state and in response to prenatal inflammation, and to investigate how these processes shape postnatal immune function.